The long-term risk of neurosyphilis in people with HIV experiencing syphilis serologic nonresponse or failure

Rates of syphilis in the U.S. have increased each year for the past 20 years and are elevated in people living
with HIV (PWH). PWH are at higher risk of syphilis complications including neurosyphilis. For decades, the
mainstay of syphilis treatment monitoring has been the serum nontreponemal antibody (NTr) titer (usually
RPR). Guidelines suggest NTr titers should decline by ≥4-fold at 12 months in adequately treated patients with
primary or secondary and 24 months in PWH or those with latent syphilis. Yet, a significant percentage (~12%)
of patients with syphilis will exhibit “serological non-response” (i.e. although asymptomatic, they have a <4-fold
decline in NTr titer). Others (1.2-24%) will exhibit “serologic failure” (i.e. asymptomatic but exhibit a sustained
>=4-fold increase in NTr titers in the absence of reinfection). Guidelines recommend those with serologic
failure should undergo lumbar puncture (LP), while serologic non-responders should be retreated with 3 doses
of benzathine penicillin G (BPG) and considered for LP, at least if follow up is uncertain or an initial high NTr
titer (>1:32) in latent syphilis does not decline. The concern in these individuals is for undiagnosed central
nervous system (CNS) infection, which could lead over time to relapse or progression to symptomatic
neurosyphilis (SNS). However, LPs come with risks and logistical challenges, additional antibiotics may not be
benign, and healthcare-related costs can be high. Currently, the best management approach (and whether LPs
and additional antibiotics are necessary) for PWH who exhibit serological non-response and serological failure
is uncertain, mainly because, in the antibiotic era, data on long term SNS outcomes in these patients are
lacking. Longitudinal data on incident SNS in PWH comparing those with appropriate serologic response,
serologic failure and serologic non-response following initial treatment are needed to inform often confusing
treatment guidelines. Prospective trials would be ideal but are impractical given the decades of follow-up and
large number of participants needed to identify this relatively uncommon outcome. We therefore propose to
leverage the Johns Hopkins HIV Clinical Cohort-a dynamic and well characterized group followed from 1990-
2024 to 1. Determine SNS incidence over time in PWH with treated syphilis and compare the incidence in
three groups: a. those who exhibit serologic non-response (i.e. <4 fold decline in NTr) b. serologic failure (i.e.
sustained ≥4 fold increase in NTr after treatment) and c. those with appropriate serological response, and 2.
Determine whether additional interventions (e.g. CSF examination and/or type and duration of antibiotic
treatment) among persons with serologic non-response or failure, are associated with improved serological
and clinical (i.e. development of SNS) outcomes. The results of this study have the potential to change national
policy, reducing unnecessary lumbar punctures and potentially antibiotic treatment in PWH with serologic non-
response or even serologic failure after initial syphilis treatment.

Public health relevance
The best management approach for people with HIV (PWH) experiencing syphilis serologic non-response or failure is uncertain, mainly because data on long-term symptomatic neurosyphilis outcomes in these patients are lacking. We propose to leverage a well characterized clinical cohort of PWH followed from 1990-2024 to: 1. Compare symptomatic neurosyphilis incidence over time in those with appropriate syphilis serologic response compared to those with serologic non-response or failure and 2. Determine whether additional interventions in those with syphilis serologic non-response or failure are associated with improved outcomes. The results of this study have the potential to change national policy, reducing unnecessary lumbar punctures and antibiotic treatment in PWH with serologic non-response or even serologic failure after initial syphilis treatment.